PTSD, AUD, and Interpersonal Conflict: Within-person associations

Summary
This application seeks to innovatively model the dynamic course of PTSD symptoms (PTSS), alcohol use
disorder (AUD), and interpersonal conflict in a sample of 250 OIF/OEF/OND veterans and test hypotheses
regarding combined effects of regulatory deficits, sleep disturbance, and the role of implicit approach /
avoidance biases. Participants will be randomized to a cognitive bias modification (CBM) training condition in a
2 (Alcohol CBM, Control) x 2 (PTSD CBM, Control) design. The longitudinal burst design will result in a high
fidelity dataset of near real-time assessments of AUD, PTSS, interpersonal conflict, and deficits in affect and
behavior regulation over the course of 2 years. Sleep disturbance will be assessed by actigraphy. The
application addresses three related questions. First, what processes link (PTSS), AUD symptoms, and
interpersonal conflict at the within-person (i.e., daily) level? We propose that acute changes (e.g., day-to-day)
in emotional and behavioral dysregulation are two pathways linking PTSS, AUD symptoms, and interpersonal
conflict at the within-persons level. Second, what contributes to reciprocal associations between PTSS and
AUD outcomes? Alcohol use has well-documented negative effects on sleep quality. Sleep disturbance is a
common symptom of PTSD and impairs emotional and behavior regulation. Sleep disturbance may explain
observed bi-directional associations. Third, why do state changes in emotional arousal and disinhibition
increase symptoms of AUD reflecting impaired control over alcohol intake? Implicit response biases are
conceptualized as a latent risk factor that influences behavior most strongly when self-regulation is impaired.
We propose that heightened emotional arousal and disinhibition associated with acute (i.e., daily) PTSS
exacerbation result in an increased effect of implicit processes on behavior. Hence, effects of implicit biases on
behavior vary across time and context. Heavy drinkers exhibit approach biases for alcohol and sexual
trauma victims exhibit avoidance biases toward trauma cues, which are related to PTSD severity. The
experimental manipulation of implicit biases paired with the longitudinal burst design follow-up will test whether
implicit response biases are related to PTSS and outcomes over time. We hypothesize that manipulating
maladaptive response biases will reduce within-person associations between PTSS, affect and behavioral
dysregulation, sleep disturbance, and the alcohol-related outcomes. The scientific premise of the application is
bolstered by a well-informed and balanced review of the empirical literature and excellent pilot data supporting
the hypotheses. The experimental design, multi-site sample, experience sampling protocol, and sophisticated
data analytic strategy contribute to a highly rigorous test of the hypotheses. The proposed project integrates
the study of implicit cognition, sleep disturbance, affect dysregulation, and behavioral disinhibition to advance
understanding of functional associations between traumatic stress, AUD, and interpersonal conflict. This study
will have high impact on the field’s understanding of mechanisms underlying PTSD and AUD comorbidity.

Public health relevance
Public Health Narrative This research will increase understanding of factors maintaining AUD and PTSD among veterans, an important public health concern. It will advance knowledge of regulatory processes underlying comorbid AUD and PTSD and associated problems with interpersonal functioning (e.g., violence). Whereas previous research has studied emotional and behavioral dysregulation as person-level correlates of PTSD and AUD, this study shifts the focus to advance knowledge of the temporal dynamics of these processes to identify time-varying precursors of health outcomes.